Causality of Post-TB Lung Disease: Population-Level Evidence from Rural Uganda

PROJECT SUMMARY/ABSTRACT
Tuberculosis (TB) is the leading single-agent cause of infectious mortality worldwide, including among people
with HIV (PWH). TB survivors also continue to experience sequelae including post-TB lung disease (PTLD)
and higher mortality. It remains uncertain, however, how much of these post-TB sequelae reflect TB itself
versus underlying pre-TB risk factors and lung disease. For example, if a substantial burden of PTLD reflects
pre-existing lung damage due to smoking – itself a risk factor for TB – then preventing TB may have minimal
effect on this burden, and we should prioritize efforts to augment smoking cessation (including among people
at risk for TB). By contrast, if PTLD development instead reflects lung damage incurred while TB diagnosis was
delayed (e.g., because people who smoke may delay seeking care for a cough), then efforts to detect TB more
rapidly – or prevent TB in the first place – are even more essential. Such questions can only be answered by
evaluating lung function and respiratory symptoms both before and after people develop TB. Performing such
a study is challenging, however, because typically no more than 1 in 500 people develop TB each year. Thus,
a large population must be followed after an initial lung function evaluation to obtain a sufficient sample size for
analysis. This proposal leverages a unique opportunity to create such a prospective cohort, as 9,000 people
from a district in rural southwestern Uganda (Rakai district) are already being recruited into a cohort study
involving lung function testing. These participants can be followed for TB and paired with an additional 20,000
people from an ongoing decades-long community-based cohort study in the same area (the Rakai Community
Cohort Study) to create a novel prospective population-based cohort for evaluating pre-TB and post-TB lung
function in an HIV-endemic African setting. In Specific Aim 1, we will characterize trajectories of lung function
before and after the development of TB disease, including among key subgroups (e.g., PWH). This aim will
enable us to infer the fraction of post-TB lung function deficits that are attributable to TB itself versus reflective
of underlying lung vulnerability. In Specific Aim 2, we will identify pre-TB characteristics and biomarkers that
are associated with a higher burden of future PTLD – both through higher risk of developing TB and higher risk
of experiencing PTLD if TB develops. This aim will enhance our understanding of PTLD pathophysiology and
identify key subpopulations that might benefit from interventions to prevent TB or mitigate its consequences. In
Specific Aim 3, we will use population modeling techniques to project the likely long-term impacts of different
interventions on the population burden of post-TB illness. These results will enable policymakers to better
prioritize those interventions most likely to have the greatest impact when delivered to specific key populations.
In summary, the proposed study will make use of a novel “window of opportunity” to better understand lung
function in TB survivors – before they develop TB in the first place. This understanding will facilitate a more
effective response to averting and/or mitigating the tremendous burden of post-TB illness worldwide.

Public health relevance
PROJECT NARRATIVE Tuberculosis (TB) is the world’s leading infectious killer – but nearly half of the total burden of TB illness may be felt not during the initial illness, rather through long-term sequelae. What is not well understood is how much of this post-TB illness is due to TB itself, versus pre-existing risk factors and/or lung disease, and addressing this knowledge gap could inform policy recommendations about which interventions might best mitigate the burden of post-TB illness. This proposal will make use of existing research infrastructure to create a novel population-based cohort in an HIV-endemic rural African setting (Rakai, Uganda), through which we can study the burden of post-TB illness using the lens of pre-TB lung function and respiratory symptoms.